META2 - Mentor, Educate, Train, Advocate: Patient Oriented Researchers inCardiometabolic Disease

PROJECT SUMMARY/ABSTRACT
Latha Palaniappan, MD, MS is a Professor of Cardiovascular Medicine and of Epidemiology and
Population Health in the Department of Medicine at Stanford University and is a well-recognized clinical
researcher with a long track record of funding, expertise, and mentoring in patient-oriented research (POR) in
cardiometabolic disease across diverse populations. This K24 renewal proposal capitalizes on Dr.
Palaniappan’s extensive clinical research and teaching experience to help her mentor and train the next
generation of clinical and translational scientists in POR. Having completed over 240 studies spanning 24
years, Dr. Palaniappan is a nationally and internationally recognized leader in chronic disease prevention
research with a focus on cardiometabolic risk among diverse populations.
Dr. Palaniappan aims to build upon the successes of her initial K24 award through this Mentor,
Educate, Train, Advocate: Patient Oriented Researchers in Cardiometabolic Disease (META2) renewal. The
Specific Aims of this renewal proposal are to: 1) engage mentees by leveraging her extensive experience to
provide an exceptional environment for POR training, 2) expand the impact of Dr. Palaniappan’s mentorship by
imparting mentorship and leadership skills to her new mentees to facilitate their transition into independent
researchers, and 3) enhance mentorship skills through further career development and mentorship training.
Through the initial K24, her 7 junior faculty mentees have achieved research and funding independence,
securing 5 career development awards (4 Ks, 1 Foundation) and 5 R-level grants. They have authored 566
papers with 176 as first author. Through META2, she aims on recruiting 1-2 new mentees per year.
POR is critical for the translation of scientific knowledge into population health benefits - it is key for the
POR workforce to be highly trained and to reflect the diversity we see in the world. Effective mentoring at early
career stages is necessary to support POR scientists in becoming independent investigators. Dr.
Palaniappan’s breadth of experience provides an innovative and dynamic setting to train mentees in POR. Her
mentees can leverage the existing research platform available through her recently completed NIH studies
(IMPACT, STRONG-D) as well as her newly funded AHA and NIH projects (TOTAL, ARISE). The projects in
her research portfolio are complementary and well positioned to expand on the fruitful work done through
META. Paired with Dr. Palaniappan’s mentee-centered mentorship, these projects are rich with opportunities
for mentees to further their training and hone their POR skills. Her research agenda is reinforced by teaching
and mentoring activities to develop the trainees’ and her own skillset in data science. Mentoring a diverse
variety of trainees in POR not only provides a multidisciplinary and intellectually stimulating environment that
promotes community, but also creates successful independent investigators and future leaders in POR.

Public health relevance
PROJECT NARRATIVE A capable, highly trained workforce of patient oriented researchers is necessary for the continuous translation of scientific advancement into improved health outcomes - it has been shown that a diverse scientific workforce leads to overall increased research productivity and quality, due to capitalizing on unique perspectives and innovative ideas. Effective mentoring at early career stages is necessary to support researchers in becoming independent patient oriented research (POR) investigators. The META2 proposal leverages Dr. Latha Palaniappan’s expertise in POR and mentorship of diverse trainees to train the next generation of POR scientists focused on cardiometabolic diseases in diverse populations.